Texas National HIV Behavioral Surveillance

DESCRIPTION (provided by applicant): The goal of the Texas National HIV Behavioral Surveillance (NHBS) project is to monitor the HIV epidemic through HIV risk behavior data of high risk groups in order to guide local HIV prevention programs in Texas and contribute to the development of a National HIV Behavioral Surveillance system. Formative research will be conducted prior to implementation of the survey using key informant interviews, focus groups, and ethnographic assessments to develop local survey questions and to identify local venues for conducting field research activities. The Texas NHBS project team will conduct an anonymous, cross-sectional survey of HIV risk behaviors, access to and utilization of HIV prevention services in three adult high risk populations, men who have sex with men (MSM), injecting drug users (IDU) and heterosexuals at increased risk of HIV (HET) in the Dallas Division, Dallas-Fort Worth-Arlington Metropolitan Statistical Area. A minimum of 500 surveys will be completed from eligible participants for each MSM and IDU cycle and 450 surveys will be completed from eligible participants for the HET cycle from January 2011 to December 2015 using venue based, time-space sampling and respondent driven sampling methodologies as appropriate for the target population. Voluntary and anonymous HIV testing will also be conducted on consenting participants to estimate HIV seroprevalence of each high risk group. Additionally, voluntary and anonymous hepatitis B (HBV), hepatitis C (HCV), and syphilis testing will be conducted on consenting participants to estimate HBV, HCV, and syphilis seroprevalence. All surveys, HIV testing, along with HBV, HCV, and syphilis testing will be conducted by a team of trained staff in a secure mobile testing unit (customized recreational vehicle). Research data will be analyzed and study findings will be disseminated to local and national surveillance reporting systems, to community based organizations, and to HIV community planning groups in order to guide prevention resource allocation and to design and evaluate prevention interventions. Further, potential research topics of key risk behavior indicators will be explored by the Texas NHBS research consortium and disseminated through abstracts, presentations, and manuscripts. The Texas NHBS will also conduct evaluations of the local NHBS system, the quality, efficiency, and usefulness of its sampling systems and data collection methods to ensure the system is meeting the project goals.

Public health relevance
Project Narrative The purpose of this proposal is to secure funds for the Texas Department of State Health Services (DSHS) to conduct National HIV Behavioral Surveillance (NHBS) in the Dallas Division of the Dallas/Ft.Worth (DFW) Metropolitan Statistical Area (MSA) in Texas. The Texas NHBS project will collect anonymous cross sectional interview data from high risk groups for HIV: men who have sex with men (MSM), injection drug users (IDU), and heterosexuals at increased risk of HIV (HET). Texas NHBS will also conduct voluntary anonymous HIV testing in each of these high risk groups to determine HIV prevalence. Additionally, DSHS is seeking supplemental funds to support hepatitis C (HCV), hepatitis B (HBV), and syphilis screening and confirmatory testing for all NHBS cycles. Background Texas DSHS has been implementing NHBS in the Dallas MSA since 2003. The year 2010 brings to conclusion two successful rounds of rotating data collection cycles for NHBS implemented by DSHS. The Dallas Division of the DFW MSA is comprised of eight counties and has a population of just over 6 million people as of July 1, 2009 (1). Dallas County has the largest county population in the division with nearly 2.4 million people. Approximately half of that number resides in the City of Dallas (1). The suburbs surrounding the city of Dallas are among the fastest growing communities in the United States (1). HIV/AIDS Morbidity Approximately 77,070 cumulative AIDS cases have been reported to CDC since the beginning of the epidemic through December 2008 in Texas (2). Texas ranks fourth in the United States in the cumulative numbers of AIDS cases (2). In 2008, there were 63,019 persons living with HIV/AIDS (PLWHA) cases in Texas (3). Just over half (54%) of PLWHA were among men who have sex with men (MSM) in Texas in 2008. Injection drug use (IDU) was the most likely route of transmission for approximately 15% of PLWHA and high risk heterosexuals accounted for 22% of PLWHA in 2008 (3). In 2008, there were 4,481 new HIV/AIDS diagnoses in Texas for a rate of 16.4 diagnoses per 100,000 population (3). The Dallas Division ranks 12th in the country in AIDS morbidity (4). At the end of 2008, there were 15,219 individuals living with HIV/AIDS in the Dallas Division of the DFW MSA (5). Dallas County, the epicenter of the HIV/AIDS epidemic in the Dallas MSA, has the second highest cumulative morbidity in the state with 13,770 persons living with HIV/AIDS after Harris County in Texas (6). The vast majority of PLWHA in the Dallas Division at the end of 2008 were located in Dallas County. Table 1 shows the number of reported HIV infections by mode of transmission and race/ethnicity in the Dallas Division of the DFW MSA in 2008. Table 1. Reported HIV Risk Mode by Race/Ethnicity for Persons Living with HIV/AIDS in the Dallas Division of the DFW MSA, 2008 Risk Mode White African Hispanic Other/ Total American Unknown n % n % n % n % N % MSM 5256 (35%) 2341 (15%) 1652 (11%) 129 (1%) 9378 (62%) IDU 297 (2%) 472 (3%) 90 (1%) 5 (<1%) 864 (6%) MSM/IDU 322 (2%) 233 (2%) 69 (<1%) 7 (<1%) 631 (4%) Heterosexual 314 (2%) 1232 (8%) 297 (2%) 34 (<1%) 1877 (12%) Other/Unknown 506 (3%) 1472 (10%) 442 (3%) 49 (<1%) 2469 (16%) Total 6695 (44%) 5750 (38%) 2550 (17%) 224 (1%) 15219 (100%) Source: Texas DSHS HIV/AIDS Reporting System (HARS) Hepatitis B (HBV) & Hepatitis C (HCV) and Syphilis Morbidity HBV and HCV: HBV and HCV infections are among the most common blood borne infections in the United States. In Texas, the rates of HBV and HCV in 2009 were 1.7 per 100,000 and 0.1 per 100,000 respectively (14). An estimated 387,395 Texans (1.79%) are infected with HCV, however, most of the infected individuals are asymptomatic and do not know their infection status. (7). Incidence rates (per 100,000) of HBV and HCV among high risk groups in the United States in 2007 are shown in Table 2 (9). Prevalence estimates for co-infection with HIV in 2007, was approximately 10% for HBV and approximately 25% for HCV in the United States (9). Table 2: HBV and HCV incidence rates among high-risk groups in the United States, 2007 Risk Mode HBV HCV Rate per Rate per 100,000 100,000 High Risk Hetero Sexual (HET) 36.7 Not available Men who have sex with men (MSM) 11 10 Injection Drug Users (IDU) 15 48 Source: The Centers for Disease Control and Prevention. Surveillance for Acute Viral Hepatitis - United States In the Paso del Norte Collaborative study, Texas DSHS joined efforts with the New Mexico Department of Health and the University of California at San Diego to study the seroprevalence of bloodborne infectious and associated risk behaviors among IDU in the region situated where the borders of Mexico, Texas, and New Mexico meet. Using respondent driven sampling, 155 IDU participants were recruited in El Paso, Texas. In El Paso, HBV was seen in 48.6% of participants, HCV in 76.4%, HIV in 10.0%, and syphilis in 9.9% of participants (10). Specimens collected in Texas were tested by the Texas DSHS laboratory in Austin . Syphilis: Syphilis is caused by the bacterium Treponema Pallidum. In the United States, around 36,000 new cases of syphilis were reported in the year 2006, including 9.756 cases of primary and secondary syphilis (P&S) (11). In 2009, over 3,583 early syphilis cases were reported in Texas and approximately 85% of these cases were interviewed by DIS (11). Twenty one percent of those interviewed had newly or previously identified HIV infection. One third of all cases interviewed were MSM. Dallas and Houston EMAs had the largest number of syphilis cases reported and interviewed in 2009. Overall, syphilis incidence rate in Texas in 2009 was 28.1 per 100,000; however, Dallas County recorded 62.7 per 100,000 cases (11). Table 3 shows the incidence rates of P&S and early latent syphilis in Texas and Dallas County in 2009 (11). Table 3: Incidence Rates (per 100,000) of Primary and Secondary, and Early Latent Syphilis in Texas, and Dallas County, 2009 Texas Dallas County Rate per 100,000 Rate per 100,000 Primary and Secondary Syphilis 6.6 12.2 Early Latent Syphilis 7.8 17.8 Source: Texas STD Surveillance Data, 2009 Significance The HIV epidemic is still taking a tremendous toll in Texas and the Dallas area. This is particularly true for White and African American MSM as well as African American heterosexuals. Since the beginning of the epidemic, HIV/AIDS surveillance nationwide and in Texas has made tremendous progress and crossed several milestones. Data collected as part of core HIV surveillance are predominantly from clinical or laboratory sources, therefore the information we have is from individuals who have already been infected and/or have visited a physician or health care provider for HIV related care. Core surveillance data provides valuable information of HIV/AIDS trends and allows estimation of prevalence rates for U.S. and Texas. These data, however, have limited use when it comes to understanding behaviors among high risk groups for HIV. High risk groups are generally referred to as hidden populations due to the difficulty in accessing them and deriving estimations of the population size. In order to develop evidence based public health programs and prevention strategies; there is a dire need to understand the risk behaviors reported by these populations, their reasons for indulging in these practices, barriers to access for health care, testing behaviors, and patterns in utilization of prevention services. The proposed study will allow the Texas DSHS to collect data regarding these specific behaviors. By understanding the overall context of the specific risk behaviors that participants engaged in, specific interventions can be appropriately tailored to address those issues. It is estimated that about 20% of persons living with HIV in the United States are unaware of their status. Another objective of the NHBS project is to determine the seroprevalence of HIV among these high risk populations. NHBS provides a way to determine HIV prevalence in populations that may not be receiving care for their infections or are not aware of their HIV status. In IDU-2 Cycle in Dallas, 16 HIV and 325 HCV positives were identified with an overall positivity of 2.6% and 55.1%, respectively (12). Co-morbidity with HBV, HCV, syphilis and HIV is also an issue among these populations groups. Most patients with HBV and HCV develop persistent infection, and develop chronic liver or other related diseases (13). Individuals infected with syphilis are at significantly higher risk for contracting HIV. Reducing the burden of these infections and related diseases requires implementation of primary and secondary prevention activities. A major goal of this supplemental project is to obtain HCV, HBV, and syphilis seroprevalence for high-risk subpopulations, identify co-morbidities, and be able to link infection status with specific risk behaviors. Research and public health will benefit from testing results, and early identification of infection should reduce the time to care and increase the efficiency of diagnosis, and the likelihood of receipt of the full protocol for hepatitis A and B vaccination and treatment services. In addition, Texas DSHS will also evaluate the knowledge and usage of the current local prevention programs by these high risk populations. Texas DSHS will include Dallas- specific questions regarding the participant's familiarity with local HIV prevention activities and the participants' access to and use of prevention services. Texas DSHS will also identify a set of local questions specific to each risk group and cycle as a result of input from Texas DSHS HIV/STD Prevention and Care Branch, Texas HIV/STD Prevention Community Planning Group, and Dallas area Community Based Organizations (CBOs). In addition to local prevention program questions, some innovative main themes that will be included in the Dallas local questions are participants' awareness of free HIV testing, awareness of rapid HIV testing, use of social networking sites to meet sexual partners, HIV prevention beliefs, and psychosocial scales measuring depression, risk taking, and social support.